ECHO in Agricultural Washington and Rural Environments (ECHO AWARE)

ABSTRACT
ECHO AWARE (ECHO in Agricultural Washington and Rural Environments) enriches the ECHO Program in
two primary ways. 1) We will increase representation of rural and agricultural communities, particularly Latino
families, in the ECHO Cohort. Rural children experience many health and environmental exposure disparities,
yet are poorly represented in research and in the current ECHO Cohort. With deep community-engaged
research ties to Washington’s agricultural Yakima Valley, our team is poised to enroll over 1000 pregnant
individuals through partnership with their medical home and Federally Qualified Health Center (Yakima Valley
Farm Workers Clinic). We also partner with Heritage University to involve Latino and Yakama Nation
undergraduates and junior faculty to exchange perspectives regarding ECHO research practice and foster
biomedical career development in this environmental justice community. Biospecimen collection will be led by
a subteam with experience directing a biorepository for >10,000 pregnancies. 2) Our investigator team (diverse
in career stage, scientific discipline, institution, cultural background) advances ECHO collaborative science in
air pollution, airway health, and rural health. We propose a new cross-cohort Rural Health Workgroup plus a
series of ECHO manuscripts to understand the health conditions and risk factors for under-resourced and
minoritized communities in rural America, as well as best practices for engaging these hard-to-reach
populations. A set of novel preconception analyses addresses widespread contaminants of concern for
drinking water wells, an underdeveloped topic for ECHO. We also leverage decades of air pollution expertise
to expand the air pollution exposures available for ECHO analyses and conduct solution-oriented research to
directly inform U.S. regulatory policy and public health promotion programs. Our team contributes expertise in
advanced methods for air pollution, including those for exposure mixtures. We also bring new national models
for outdoor air pollutants of emerging concern to ECHO, including wildfire smoke (WFS) and ultrafine
particulate matter (UFP). We first develop an improved national model for WFS to enable much-needed
research on this climate-change driven catastrophe and lead manuscripts to describe impacts on US children.
We then develop a new national model of UFP, an unregulated pollutant demonstrating high toxic potential in
animal models yet with little epidemiological data. We also propose brief, low-burden extensions to the ECHO
Protocol to better characterize rural chemical exposures as well as knowledge of the Air Quality Index (AQI) to
explore disparities in access to this public health tool and evaluate its effectiveness in mitigating health effects.
A proposed Wildfire Rapid Response Protocol will support natural experiment analyses of wildfire related
health crises. Overall, ECHO AWARE builds on prior successes and insights gained as the ECHO
PATHWAYS multi-cohort award center point for project coordination and team science; we continue these
efforts in ECHO 2.0 with a focus on solution-oriented research, community-engagement, and translation.

Public health relevance
NARRATIVE The ECHO AWARE (ECHO in Agricultural Washington and Rural Environments) project enriches the diversity of the ECHO Cohort with participants from a rural, agricultural community with a high proportion of Latino individuals. Research activities are designed to improve health of rural children; answer important questions regarding exposures of all children to common air pollutants, pesticides, and drinking water hazards; and directly inform US policy and programs. The project engages local students, community health service partners, and junior scientists to increase the diversity of perspectives in the ECHO Program as well as the impact of the research.